Optical Sensing of the Spread of Alpha-Synuclein Aggregates in Models of Parkinson's Disease and Related Dementias

The basis for the onset and progression of Parkinson's disease (PD) and related dementias remains unknown,
but the formation and spread of aggregates of the protein alpha-synuclein (aSyn) between neurons has been
identiﬁed as a likely mechanism. Thus, understanding the molecular underpinnings of this prion-like spread is
a key step that would set the stage for developing therapies to delay or alleviate PD-related motor dysfunction
and dementia. However, to date, there has been no viable method to comprehensively investigate the under-
lying phenomena of aggregation in live cells, and certainly not in vivo. The long-term goal of this research is
to deﬁne the molecular mechanisms that contribute to neurodegeneration in people with PD and related de-
mentias, in order to stimulate the development of new therapies. The overall objective of this application is to
establish a role for aSyn-mediated membrane permeabilization in the spread of aSyn neuropathology in PD.
The central hypothesis is that aSyn oligomers derived from internalized preformed ﬁbrils (PFFs) facilitate the
endocytic escape of aSyn seeds by permeabilizing the endocytic membrane from within. This hypothesis will
be addressed with the following speciﬁc aims: (i) Deﬁne aSyn assembly states in different subcellular loca-
tions of PFF-treated neurons; and (ii) Deﬁne aSyn assembly states at various stages of PFF-mediated aSyn
propagation in vivo. The project entails ﬂuorescence lifetime imaging microscopy (FLIM) studies with neurons,
where lifetime depends on aggregation level, as well as steps to application in vivo, enabled by high-resolution
three-dimensional ﬂuorescence localization with point-wise lifetime information (and hence insight into the aSyn
self-assembly state) at various positions in the brain over time. Notably, ﬂuorescence quenching and hence
lifetime reduction, similar to what occurs in ﬂuorescence resonance energy transfer (FRET), has been shown
by the group to occur when aSyn fused to a ﬂuorescent protein (aSyn-FP) undergoes self-assembly to a beta-
sheet-rich, aggregated state, with a lifetime that reduces with increasing aggregate size. This provides a means
to study aSyn aggregate formation and spread using high-resolution FLIM (Aim 1). Drawing on the group's
conceptualization and demonstration of a means to image ﬂuorescence parameters in vivo and through heavy
scatter, and also at high resolution using computational imaging with localization, ﬂuorescence lifetime param-
eters determined at a set of locations in the brain should yield aSyn aggregate and spread information (Aim 2).
Upon completion of this project, live-cell studies will have allowed aSyn aggregation and spread to be character-
ized, which should lead to understanding of the molecular process, and critical steps to optical sensing of aSyn
aggregate spread in the whole brain of animals will have been achieved. This approach is innovative because it
is focused on new technologies and research avenues related to the propagation of aSyn pathology in PD and
related dementias. The research is signiﬁcant because the new knowledge from this study would set the stage
for developing therapeutic strategies to interfere with the spread of aSyn aggregates in the brains of patients.

Public health relevance
The direct impact of this research is the clear prospect that new molecular information regarding the cause of Parkinson's disease and related dementias will become available. Armed with this understanding, it should be possible to achieve more effective treatments that will slow the progression of the disease. More generally, the ability to access protein conformation information in vivo has broad ramiﬁcations in studies of human disease extending beyond Parkinson's disease.